Caregivers as the Agent of Change for Childhood Obesity and Chronic Disease Risk Among Latino Families

Latino children have higher rates of overweight and obesity (OW/OB) and related chronic diseases, such
as type 2 diabetes, non-alcoholic fatty liver disease, and dyslipidemia. This disparity starts early in life, persists
into adulthood, and is associated with a myriad of negative cardiometabolic and psychosocial health
consequences. At present, the most effective program for weight management in children is family-based
treatment (FBT), which is delivered to the target child and a parent (typically the mother). An emerging strategy
is parent-based treatment (PBT), which provides intervention to the parent only, without the child. PBT has
several benefits, including decreased treatment costs, developmental appropriateness for younger children and
potential for broader dissemination. In ongoing trials, we have found that Latino families attend less visits and
consequently treatment in children is less effective. Thus, a tailored program for Latino families is needed that
can address cultural values and capitalize on the value of familismo. The goal of Project 2 is to test the efficacy
of a durable, feasible, culturally relevant program to treat OW/OB and reduce chronic disease risk in Latino
children and their parents. We propose a randomized clinical trial to compare a telehealth PBT for Latino families
with a health education (HE) control group on changes in child and parent weight and chronic disease risk. We
will recruit 160 Latino families consisting of at least one parent with OW/OB, at least one other willing caregiver,
and a 5-10-year-old child with OW/OB and randomize them to 6-month PBT or control. We will assess outcomes
before treatment (month 0), mid-treatment (month 3), post-treatment (month 6), and at 6- and 12-month follow-
up. Specific Aim 1 will compare the efficacy of PBT versus control on child weight (BMIz) over 18 months. Specific
Aim 2 will determine the efficacy of PBT on parent BMI, child and parent diet and physical activity, home food
environment, parent feeding behaviors and parenting confidence and self-efficacy. Specific Aim 3 will determine
the efficacy of PBT on child and parent biomarkers of risk of type 2 diabetes, liver function and dyslipidemia. In
an exploratory aim we will evaluate the impact of potential moderators (e.g., parent and child gender and age,
acculturation level, parent education) and mediators (e.g., change in home food environment, parent feeding
behaviors, family functioning) on intervention efficacy. In a cross-center aim, data from this Project will be
combined with Projects 1 and 3 to examine the multi-level determinants of chronic disease risk in Latino children,
and how social and environmental factors affect the response to different types of interventions in Latino families
for reducing chronic disease risk. The development of interventions for Latino children with OW/OB that address
cultural values around food and the importance of family structure are needed to increase acceptance and
adherence to lifestyle changes, and to improve chronic diseases risk, not just in children but also in parents.
Further, delivering this intervention via telehealth will increase the reach of this intervention, decrease family
burden, lower the cost and make it more broadly appealing for dissemination to a wider audience.